Elucidating the Pathomechanisms of APOE4 in Lewy Body Dementia

PROJECT SUMMARY
The proposed studies seek to investigate the underlying disease mechanisms of Lewy body dementia
(LBD) associated with the apolipoprotein E4 (APOE4) isoform. APOE4 is a major genetic risk factor for LBD,
and our recent research has shown a direct influence of APOE4 on α-synuclein (αSyn) pathology in the
human brain and mouse models. However, the mechanistic relationship between APOE4 and LBD remains
unclear. APOE, primarily produced by astrocytes, mediates cell-to-cell lipid transport in an isoform-dependent
manner. APOE4 is known to disrupt brain lipid homeostasis and compromise the endosomal-lysosomal
system, which are pathways also associated with other LBD hits, GBA and BIN1. This suggests that these
pathways may be key mechanisms linking APOE4 to LBD. Moreover, APOE4 is associated with the risk and
severity of LBD, but not necessarily Parkinson’s disease (PD). This leads to the speculation that the effects of
APOE4 on αSyn pathology may manifest more in the neocortex where LBD pathologies are found and have
minimal impact on subcortical or brainstem structures where Lewy pathology is predominant in PD. Therefore,
the proposed research aims to investigate the role of APOE4 in αSyn pathogenesis and define the underlying
molecular pathways and brain region vulnerability using human postmortem brains, astrocyte-specific APOE3
or APOE4 deletion mouse models, and human induced pluripotent stem cell (iPSC)-derived organoid models.
In Aim 1, we will perform multi-omics profiling (bulk RNA iso-seq, single nuclei RNA-seq, proteomics, and
lipidomics) of the superior temporal cortex and midbrain of human LBD cases from APOE3/3 and APOE4/4
individuals. We will conduct network analysis to uncover lipid and endosomal-lysosomal related dysfunction,
and other pathways associated to LBD and APOE4. In Aim 2, conditional mouse models will be used to delete
APOE3 or APOE4 in astrocytes by crossing human APOE knock-in mice, where murine Apoe is replaced with
floxed APOE3 or APOE4 gene, with Aldh1l1-CreER mice and human SNCA-overexpression mice. Deletion of
APOE will be induced by tamoxifen treatment at different stages of αSyn pathogenesis. The αSyn pathology
related phenotypes will be evaluated and multi-omics profiling will be conducted in the experimental mice. In
Aim 3, we will validate the cellular mechanisms of APOE4 on affecting αSyn pathogenesis, lipid homeostasis,
and endosomal-lysosomal functions using iPSC-derived cortical and midbrain-like organoid models from
patients carrying SNCA triplication and different APOE genotypes edited by CRISPR/Cas9 technology.
Together, this innovative proposal will utilize unique human brain resources, mouse models, and human iPSC-
derived models, and combine state-of-the-art approaches for multi-dimensional integration of molecular
profiling to comprehensively investigate the pathomechanisms of APOE4 in LBD. These efforts will contribute
to our understanding of the APOE4-mediated pathways involved in αSyn pathology, providing valuable
insights for the development of future therapeutic strategies targeting APOE in the treatment of LBD.

Public health relevance
PROJECT NARRATIVE Lewy body dementia is a leading cause of Alzheimer’s disease related dementia affecting a large population of our aging society, yet we still do not fully understand the disease mechanisms and thus have no effective way to treat this devastating disease. Towards this, the goal of this proposal is to understand the molecular etiology of Lewy body dementia by studying the strongest genetic risk factor APOE4 which has been shown to have a direct influence on α-synuclein pathology in the human brain and our in vivo mouse models. Herein, we propose to use a multi-omics approach to profile human postmortem brains and utilize mouse model and human induced pluripotent stem cell-derived model to study disease mechanisms and validate the underlying molecular pathways of APOE4-related α-synuclein pathogenesis to inform targeted therapeutic intervention strategies in Lewy body dementia.